Discovery of GPR52 ligand probes for cocaine use disorder

PROJECT SUMMARY
Abuse of psychostimulants represents a major public health problem in the United States. Continued misuse of
stimulants escalates in vulnerable individuals to a substance use disorder (SUD). SUDs are debilitating
conditions evidenced by sustained, clinically significant health consequences and there is a critical unmet need
to discover therapeutic strategies to normalize mechanistic drivers of cocaine use disorder (CUD) and treat CUD
effectively. Using an informatics approach comparing RNA expression in human brain subregions versus other
tissues, we identified GPR52, a novel orphan G protein-coupled receptor (GPCR), that is selectively and highly
expressed in dopamine D2 receptor (D2R) pathway medium spiny neurons (MSNs) in the nucleus accumbens
(NAc). The dopamine (DA) D2R pathway is highly relevant as recent neurocircuitry studies strongly support the
hypothesis that D2R striatal reward pathways underlie the processes involved in the development and
maintenance of CUD. We have determined that GPR52 is a Gαs/olf-coupled receptor that activates adenylyl
cyclase to stimulate production of the second messenger cyclic adenosine monophosphate (cAMP) which
induces a functional crosstalk with D2R cAMP signaling and increases NAc D2R MSN excitability. We propose
that GPR52 is a promising novel target for CUD and possibly other SUDs. We have recently established and
validated GPR52-based cellular assays and designed a novel series of small molecule GPR52 agonists,
identifying the tool compound PW0787 which evoked the profile of a selective GPR52 agonist in vitro and in vivo
to suppress stimulant-induced psychomotor behavior in mice. In more recent studies, we have identified the first
GPR52 G protein-biased agonist probes (e.g., PW0671), which show reduced β-arrestin engagement with
reduced GPR52 desensitization. We hypothesize that selective small molecule G protein biased GPR52 agonists
will have superior target efficacy and provide an optimal strategy to normalize NAc MSN signaling pathways
strongly linked to CUD processes. Our objective is to create and evaluate GPR52 agonist probes with favorable
pharmacodynamic and drug metabolism and pharmacokinetics (DMPK) profiles, and evaluate select molecules
in proof-of-concept in vivo models. The proposed studies are significant as our discovery program will provide
valuable, chemically unique and optimized GPR52 agonists to be explored as SUD therapeutics and serve as
neuroprobes to understand fundamental GPR52 mechanisms at cellular, physiological and behavioral levels.
The execution of the Aims of this project will considerably advance scientific understanding of GPR52 activation
as a therapeutic target, and place us on a trajectory to drive medication development for CUD and possibly other
disorders.

Public health relevance
PROJECT NARRATIVE Cocaine use disorder (CUD) remains a significant health problem without any medication assisted therapy yet available. The present project will create novel small molecule activators of the brain receptor GPR52 and evaluate if this new target and drug activators reduce cocaine taking or seeking in preclinical studies. This project will ultimately allow creation of new GPR52 drug activators and evaluate these compounds as an investigational treatments for substance use disorders and related neuropsychiatric disorders.